FAD Mutations in the Amyloid Precursor Protein

Context of this Project in the Sanders Lab The preliminary phase of this project is funded by the National Institute of Aging (NIA) under the R21 "Exploratory/Developmental Research" program (PA-03-107). After administrative cuts to the original project budget, this R21 was funded for two years at <$120,000 direct per year over two years: 5/01/06-4/30/08. The R21 grant is non-renewable and is not eligible for conversion to an RO1 via competitive renewal. Therefore, this PPG proposal represents an effort to secure support in the form of a new grant to continue this work. There is one month of overlap between the proposed start date of this PPG (04/01/2008) and the end of the R21 that will need to be addressed at the administrative level if this PPG is funded. Data generated with the support of the R21 is presented here in the form of "Preliminary Data".